Investigating the Role of Mutagenic DNA Repair during the Persistence of Cancer Cells

PROJECT SUMMARY/ABSTRACT
Our cells possess multiple mechanisms for repairing DNA to safeguard our genomes. While predominantly
error-free pathways such as homologous recombination (HR) are responsible for maintaining genomic integrity,
low-fidelity repair mechanisms such as non-homologous end joining (NHEJ) contribute to genomic plasticity.
When cells are under extreme stress, such as being exposed to anti-cancer drugs, they enter a state of
persistence where low-fidelity DNA polymerases are upregulated and HR is downregulated, shifting
dependence of DNA repair to error-prone mechanisms. If mutations occur in genes targeted by the anti-cancer
drug, they can result in acquired drug resistance and lead to cancer relapse. In BRCA1/2-mutant cancers,
which are HR-deficient, initial tumor response to DNA-damaging poly-ADP ribose polymerase (PARP)
inhibitors is mitigated by reversion mutations that restore BRCA1/2 function and therefore HR. These
resistance-conferring reversion mutations are often flanked by regions of microhomology, suggesting the
involvement of the mutagenic DNA repair pathway, microhomology-mediated end joining (MMEJ). In colorectal
cancer (CRC), initial tumor response to epidermal growth factor receptor (EGFR) blockade is mitigated by
acquired resistance-conferring point mutations in EGFR, KRAS, and other genes. As such, understanding
persistence and mutagenic DNA repair is critical for studying and treating cancer. However, the specific
mechanisms that promote mutagenic DNA repair and drive acquired drug resistance in persister cancer cells
remain unclear. We hypothesize that cellular stress induced by anti-cancer drugs rewires DNA repair pathways
in persister cancer cells, increases their reliance on mutagenic DNA repair—by MMEJ—and drives the
emergence of acquired resistance mutations. This proposal describes work to define the role of MMEJ in
persistence-mediated acquired resistance in cancer cells by (1) investigating persistence in response to PARPi
treatment of BRCA1/2 cancer cells; (2) examining mechanisms of mutagenic DNA repair in persister colorectal
cancer cells; and (3) using high-content microscopy to determine a morphological signature of persistence.
Given the clinical importance of persistence in cancer, this work has the potential to directly impact cancer
treatment by identifying potential therapeutic targets, particularly regulators of MMEJ, that could reduce
persistence-mediated relapse. Leveraging the sponsor’s, Agnel Sfeir’s, expertise in DNA damage repair and
commitment to mentorship, Anne Carpenter’s support of the morphological profiling component, and the
training institution’s, Sloan Kettering Institute’s, extensive network of core facilities, cancer-focused seminars,
and commitment to supporting postdoctoral fellows, this trainee and project are well-positioned for success.
Together, these investigations will provide a thorough and systematic evaluation of DNA repair and morphology
in persistence while preparing the trainee for a career as an independent researcher.

Public health relevance
PROJECT NARRATIVE Persistence is a transcriptionally distinct cellular state that occurs in response to environmental stressors and toxins, similar to the SOS response in bacteria. Exhibiting slowed cell proliferation, upregulation of low-fidelity DNA polymerases, and hypermutability of the genome, small populations of persister cancer cells survive prolonged toxic onslaughts from anti-cancer drugs and expand once the stress is removed or after acquiring a resistance-conferring mutation. Here, I aim to undertake a systematic evaluation of mutagenic DNA repair pathways that contribute to persistence in cancer cells, thereby identifying potential new targets for anti-cancer therapy to prevent acquired drug resistance and establishing a morphological signature of persistence.